Hippocampal modulation of subcortical circuits in the control of emotional behavior

Project Summary
Almost a third of adult Americans suffer from an anxiety disorder, carrying an enormous
personal, societal and financial burden. Anxiety disorders are complex circuit-based conditions,
resulting from dysfunction in a number of distributed regions, connections, and cell types that
generate normal adaptive behavior. Thus, a deeper understanding of how these neural circuits
become disrupted to generate maladaptive behavior is crucial if we hope to generate new
treatments. In recent years, we have shown that the ventral hippocampus (vHPC) is an central
node in the extended circuit that generates adaptive avoidance behavior. However, the input-
output organization of the ventral hippocampus in the control of anxiety-related behavior
remains poorly understood. Here, we will use functional imaging of large populations of
anatomically defined vHPC neurons, optical manipulation of these neurons, and high resolution
behavioral analyses to expand our understanding of how the extended ventral hippocampal
network controls behavior. We will first determine the encoding properties of vHPC output
neurons to subcortical areas known to drive avoidance and anxiety-like behavior. Then, we will
adopt new unsupervised behavioral classification tools for understanding anxiety-related
behavior in mice to determine how vHPC projection neurons orchestrate distinct behavioral
states. Finally, we will determine how distinct inputs to the differentially modulate avoidance
behavior and shape anxiety-related representations in vHPC. This will provide the most detailed
functional map of the extended hippocampal circuit that controls avoidance behavior, and
provide novel targets for generation of therapeutics for the treatment of anxiety disorders.

Public health relevance
Project Narrative In this proposal, we describe experiments aimed at understanding the distributed circuits that generate adaptive avoidance behavior, and how they may become disrupted in states of increased anxiety. Understanding these circuits is the first step in the generation of novel, targeted, circuit based therapeutics for the treatment of mood and anxiety-related disorders.